Infertility History and Chronic Disease Profile

Project Summary/Abstract
Infertility is a common disease, which affects 1.5 million women each year in the United States. It is
heterogeneous in both etiology and severity, with different biologic mechanisms causing different types of
infertility. While women suffering from infertility are known to have a higher risk of many adverse pregnancy
outcomes, research suggests that these women may also be at increased risk of chronic diseases later in life,
and NIH has prioritized the need to understand infertility as a potential marker for a woman’s overall health (PA-
17-091, “Fertility Status as a Marker for Overall Health”). Prior research on the long-term health of women with
infertility has been limited by studies with short duration of follow-up, low statistical power, and inability to take
heterogeneity of infertility diagnoses, fertility treatment, and chronic diseases into account. Our proposal
combines extensive phenotypic data from 116,430 participants Nurses’ Health Study II collected prospectively
over 30 years of follow-up, biologic samples, and genetic data to address these gaps in the existing literature.
Our long-term goal is to understand whether women who have experienced infertility have adverse long-term
health compared to women who never experienced infertility and the factors that underlie these differences. Our
specific aims will address: Aim 1: Chronic disease incidence: Evaluate the relationship between infertility
(overall and by subtype) and the risk of cardiovascular diseases (myocardial infarction and stroke), type 2
diabetes, and breast cancer. Aim 2: Biomarkers of chronic disease: Investigate whether women who
experienced infertility have altered inflammatory, cardiometabolic, and hormonal biomarker profiles compared to
women who have not experienced infertility. Aim 3: Shared genetics: Evaluate whether women experiencing
infertility have a different genetic profile compared to women never experiencing infertility using bi-directional
mendelian randomization. No studies have utilized these combined phenotypic, biologic, and genetic data at the
scale required to address fundamental public health questions related to the long-term health of women with
infertility – a scientific gap that we address in this proposal. As approximately one in six women experience
infertility, the potential public health impact of understanding the relationship between infertility and long-term
health demands pursing research in this area. These aims represent a rigorous and efficient opportunity to
investigate infertility in relation to women’s overall long-term health trajectory.

Public health relevance
Project Narrative In response to PA-17-091, within the Nurses’ Health Study II (a prospective cohort of 116,430 women followed for >30 years), we will combine data from women’s infertility and infertility treatment history, stored blood samples collected at two time points during follow-up (1st and 2nd collection, 10 years apart), and genome- wide data to evaluate the relationship between infertility and the risk of cardiovascular diseases (myocardial infarction and stroke), type 2 diabetes, and breast cancer, including inflammatory, cardiometabolic, hormonal, and genetic profiles.